Translating Pediatric Cancer Proteogenomic Data into Biological and Clinical Insights

Project Summary
This project aims to harness proteogenomic data to advance biological understanding and therapeutic
opportunities for pediatric cancers. Building on our leadership in the Clinical Proteomic Tumor Analysis
Consortium (CPTAC), where we co-led over half of the flagship studies, we will apply our established analytical
frameworks and specialized tools to multi-omics data from the Kids First Pediatric Research Program and
Childhood Cancer Data Initiative (CCDI). Our initial focus includes brain tumors and leukemias such as
medulloblastoma, ependymoma, high-grade glioma, ATRT, AML, and T-ALL. Available data span whole exome
sequencing, RNA-seq, proteomics, phosphoproteomics, acetylomics, ubiquitylomics, glycoproteomics, and
metabolomics. We will lead integrative analyses across four key areas: 1) Neoantigen Discovery: Using our
NeoFlow2 pipeline and PepQueryMHC algorithm, we will identify and prioritize tumor-specific and non-canonical
antigens for immunotherapy development. 2) Protein Isoform Analysis: Applying SEPepQuant, we will resolve
isoform-level expression and regulation, integrating proteomics and transcriptomics to reveal novel biological
features relevant to pediatric tumorigenesis. 3) PTM Analysis: Leveraging our suite of tools—including
LinkedOmics, IDPpub, and CoPheeMap—we will investigate signaling dynamics, subtype-specific pathways,
and actionable PTM events. 4) Pathway and Network Analysis: We will deploy WebGestalt, FunMap, and
LinkedOmics to interpret multi-omics data, uncover dysregulated networks, and generate mechanistic
hypotheses with therapeutic potential. Our workflows are scalable, modular, and cloud-enabled, ensuring rapid
deployment and interoperability with other PGDAC pipelines. We will collaborate closely with PGDAC partners,
data generators, and disease experts to maximize impact, deliver biologically grounded insights, and support
precision oncology for children with cancer.

Public health relevance
Project Narrative This project will apply advanced proteogenomic analysis to multi-omics data from pediatric brain tumors and leukemias to uncover biologically and clinically relevant insights. Leveraging our validated computational pipelines and specialized tools for antigen discovery, protein isoform resolution, PTM interpretation, and pathway/network analysis, we aim to identify tumor-specific features and therapeutic vulnerabilities. The results will inform mechanistic understanding and support precision oncology strategies tailored to pediatric cancers.